NIH Diversity Supplement (R00-CA-256351)

PROJECT SUMMARY
Ms. McKenzie Reese is an undergraduate researcher at Loyola Marymount University (LMU) seeking
additional training, mentorship, and career development in psycho-oncology research. This diversity
supplement will support Ms. Reese to contribute to an ongoing pilot RCT of an adapted Mindful Self-
Compassion intervention that aims to reduce stigma among adults with lung cancer (R00CA256351). Given
the racial disparity in the incidence of lung cancer, it is important to promote full representation of African
American patients in cancer research. However, African American cancer patients are less likely to enroll in
clinical trials and experience higher attrition in longitudinal psycho-oncology research, as compared to White
patients. As such, there is a crucial need to identify strategies that promote the recruitment, engagement, and
retention of African American cancer patients in psycho-oncology research. In this project, the candidate will
address this need by 1) assessing whether culturally-relevant messages and images within the parent study’s
Facebook Targeted Advertisement recruitment strategy will promote research participation among African
American lung cancer patients and 2) evaluating motivational factors that underlie patients’ continued
participation in the parent study by analyzing qualitative interviews post-intervention. Alongside these research
aims, the candidate will pursue mentoring and career development activities to gain fundamental and
advanced research skills in psycho-oncology, which will accelerate the candidate’s trajectory toward a career
in cancer research. These aims are aligned with NCI’s 2023 annual plan for breaking down barriers to clinical
trial participation and the goals of NCI’s Equity and Inclusion Program. Successful completion of this project
will provide the candidate with the opportunity to see a research project through from recruitment to
dissemination, receive in-depth research training, and participate in career development workshops that will
enhance her competitiveness and preparation for graduate programs in psychology, thereby supporting her
long-term goal of becoming an independent scientist focused on reducing cancer-related health disparities.

Public health relevance
PROJECT NARRATIVE African American cancer patients are less likely than White patients to enroll in clinical trials and experience higher rates of attrition in longitudinal psycho-oncology research, and understanding strategies that promote successful recruitment, retention, and engagement of African American lung cancer patients in an ongoing pilot RCT of an adapted mindfulness intervention (R00CA256351) can contribute to NCI’s goals of breaking down barriers to clinical trial participation and efforts to ensure that participant samples in cancer research are fully representative. In this project, the candidate will 1) assess whether culturally-relevant messages and images within the parent study’s Facebook Targeted Advertisement recruitment strategy will promote research participation among African American lung cancer patients and 2) evaluate motivational factors that underlie patients’ continued participation in the parent study by analyzing qualitative interviews post-intervention. Alongside these research aims, the candidate will pursue mentoring and career development activities to gain fundamental and advanced research skills in psycho-oncology, which will accelerate the candidate’s trajectory toward a career in cancer research.